South Texas Alzheimer's Disease Center Clinical Core

Abstract
The Mexican-American (MA) Hispanic community is the most rapidly growing minority and is disproportionately
affected by Alzheimer’s disease and related dementias (ADRDs). Nonetheless, the prevalence, predictors,
biology and clinical course of dementia, and the care needs of this population remain understudied. The Clinical
Core (CC) of the South Texas Alzheimer Center (STAC) will establish a new culturally, socioeconomically, and
geographically diverse cohort in this underserved region. Recruitment will be done at 3 core sites (San Antonio,
Laredo and Harlingen, TX) using identical protocols. The CC will collect all the prescribed Uniform Dataset (UDS)
data and collaborate with the Imaging (IC), Biomarker (BC), Genetics and Multiomics (GMC) and
Neuropathological (NPC) cores to establish the brain morphology (ADNI3 protocol MRI, amyloid and tau PET),
biomarker (blood, CSF, sensory-motor), genomic (clinical tests, APOE, GWAS, WGS) and pathological
correlates of clinical syndromes to advance our understanding of the heterogeneous pathophysiological
processes underlying ADRDs, especially in MA, using precision medicine approaches. In partnership with the
Population Neuroscience Core (PNC), the CC will define risk and resilience factors for dementia by examining
the impact of vascular, lifestyle, medical comorbidities, environment, culture, and social determinants (UDS+
data) on the transition from normal cognitive aging to dementia. In addition, the CC will create a trial-ready
caregiver registry, examine a caregiver sample (same tests as patients except for PET and LP), and will study
the interactional effect of the patient/caregiver dyad on disease course, care needs, and health outcomes. The
CC will annually enroll 140 individuals with MCI or dementia and 60 cognitively normal controls; >50% will be of
MA ancestry and at least 30% from underserved areas to establish a diverse longitudinal clinical cohort of ~700-
800 persons by year 4 (Aim 1a). The CC will also recruit all care partners of individuals in the clinical cohort into
the caregiver registry and intensively study all willing caregivers, ~45/year from dyad and ~20 who provide care
to ADRD patients who may be too advanced to enroll (Aim 1b). Within these cohorts, the CC will assess the
prevalence of novel and established ADRD biomarkers of pathology, risk, and resilience with disease course
and prognosis (Aim 2a). The CC will provide comprehensive care throughout illness, enabling deep longitudinal
phenotyping and annual collection of biospecimens (BC, NPC), assessing serial change in imaging (IC), and
clinicopathological correlations at autopsy (NPC). The approach will promote engagement (OREC), education
(REC), and clinical trials for all disease stages (Aim 2b). The CC will also genetically characterize the cohort
(Aim 3) and identify biomarkers for biological characterization of Suspected Non-Alzheimer Pathology (SNAP,
A-/N+) in persons with and without diabetes (Aim 4). The DMSC will ensure timely, quality data collection and
sharing. In summary, the CC will identify risk/resilience factors, utilize precision medicine approaches to improve
risk-stratification, diagnosis, and prognosis, and enhance research recruitment of a predominantly MA cohort.